Reproductive and Child Health Trajectories in the Context of Public Health Crises

Modified Project Summary/Abstract Section

The objective of this proposed research is to provide one of the first in-depth, mixed-method analysis of women’s reproductive trajectories in the context of public health crises in a country hard-hit by such crises. These analyses will center on how contextual and individual-level experiences with these public health shocks have influenced women’s reproductive lives both in the short-term and long-term. Understanding women’s reproductive responses to infectious disease crises is key to developing a nuanced understanding of how the impact of these shocks extend beyond mortality to fertility and reproductive wellbeing. With the increased risk of novel infectious disease crises, it is pertinent to consider how the successive nature of such population health shocks have lasting, interconnected implications for the course of women’s reproductive lives. This is especially important in the context of a developing country where vast inequalities in economic security, healthcare access, unintended pregnancy, and morbidity and mortality persist. Currently, little population-based data or research is available on how women’s reproductive trajectories have evolved through different stages of public health crises anywhere. To address this, the proposed study will expand upon an existing three-year longitudinal study (DZC-1), the first-ever panel study on women’s reproductive lives in South America of any kind, for an additional three years to generate one of the longest empirical records of reproductive trajectories of a multi-age cohort (ages 18-34 in 2020) of women (DZC-1-2). This data will be collected twice each year for the next three years and include information on individual and municipality contextual experiences, reproductive intentions, behaviors, and outcomes (with questions on monthly contraceptive use history and relationship history), and a range of potential mediators such as risk perceptions, knowledge about disease transmission, economic vulnerability, healthcare access, and contraceptive self-efficacy. We will link new waves of data with DZC-1 waves to understand if, and how, the experience of living through successive public health crises produces immediate, lagged, and compounded effects. We will also merge DZC 1-2 data with municipality and census tract data to address the implications of contextual conditions on reproductive processes. In addition to creating a 6-year panel, the aims of this study are to examine how varied individual and contextual experiences across space and time have influenced women’s reproductive lives, including their child’s health. We will use panel data methods and difference-in-difference models for our proposed analyses. We will add nuance to these analyses with in-depth interviews to understand how women classified as outliers navigated pregnancy during public health crises.

Public health relevance
Modified Public Health Relevance Section The proposed study will expand an existing longitudinal study (DZC-1), the first panel survey of reproductive lives in a large South American country, to lengthen the observation interval of respondents by three years stands to generate one of the longest empirical records for examining the reproductive lives of a multiage (18-34 in 2020) cohort of women (and their children) in response to highly consequential back-to-back public health crises. With established rapport with the community and instituted local survey capacity, our proposed approach advances critical knowledge on the extent to which back-to-back generalized public health crises, which have become increasingly common, are consequential to women’s reproductive lives, including their young children’s health. The findings promise to advance research and theory on back-to-back novel infectious disease shocks by examining individual- and contextual-level effects on women’s reproductive lives and trajectories, which can inform policy and outreach efforts to reduce unmet need for contraception and unintended fertility amidst major reproductive health crises.